Cleveland NeuroDesign Entrepreneurs Workshop

PROJECT SUMMARY
The journey from health research to patient-centered solutions, especially in the realm of neural engineering
and neurotechnology, presents numerous challenges. These span from the intricacies of clinical requirements
to the complexities of regulatory landscapes. Moreover, traditional academia doesn't always prepare students
for the commercial aspects of their innovations. Addressing this need is the Cleveland NeuroDesign
Entrepreneurs Workshop (CNEW). Modeled after Stanford's Biodesign framework, CNEW equips
neurotechnology researchers and entrepreneurs with the skills needed to transform their scientific concepts
into viable commercial solutions. Hosted annually at Case Western Reserve University, the workshop gathers a
select cohort of 32 participants. These attendees, grouped into teams, embark on a journey from identifying
clinical needs to presenting a business pitch. The program offers a rich blend of lectures, real-world case
studies, and mentorship, culminating in a pitch competition evaluated by industry experts. Having conducted
four iterations, CNEW has established its effectiveness in fostering entrepreneurial self-efficacy (Aim 1) and
promoting long-term professional growth in the neurotechnology sector (Aim 2). The workshop's track record
showcases its role in transforming participants into adept professionals, ready to innovate in the field of
neurotechnology. For the upcoming 5th iteration in September 2024, we are seeking partial funds via this R13
application. Our institution is fully supportive, with recurrent faculty involvement. Aiming to widen our impact,
we are amplifying our outreach to underrepresented STEM communities, ensuring a more diverse and
inclusive participation.

Public health relevance
PROJECT NARRATIVE The Cleveland NeuroDesign Entrepreneurs Workshop is an innovative initiative designed to equip neurotechnology professionals with entrepreneurial skills, fostering the translation of cutting-edge research into practical applications. By propelling the development of novel neurotechnologies, the workshop contributes to our understanding of the human nervous system and accelerates the creation of advanced therapeutic solutions. In the long run, this can enhance the health and quality of life of individuals affected by neurological disorders, while reducing the societal burden of these illnesses.